Novel Methods to Assess Interfragmentary Motion: Quantifying a Critical Factor in Fracture Healing

PROJECT SUMMARY/ABSTRACT
We seek to understand how variations in surgical fixation and rehabilitation protocols for distal femur fractures
impact the mechanical environment at the fracture and how this in turn influences healing. The concept of
mechanotransduction, where physical forces are converted into biomechanical signals that guide cellular
responses, is relevant to the healing of all human fractures. Distal femur fractures treated with locked plate
fixation are an excellent model for study given a relatively high rate of healing complications (in up to 32% of
cases) and a range of treatment strategies across a wide variety of mechanical conditions. The challenges faced
when attempting to provide stable, yet biologically friendly (i.e., promoting secondary fracture healing) fixation at
this site typify those encountered for all long bone fractures. Although the clinical importance of
mechanotransduction in bone healing—in particular strain across a fracture site—has been qualitatively
demonstrated, there is a lack of quantitative data. Its specific mechanisms are not fully characterized, and
progress to improve related clinical outcomes [has been stagnant. A lack of quantitative clinical data limits our
ability to design surgical techniques, implants, and rehabilitation protocols to optimize healing outcomes.
Currently, a major obstacle in the field is an inability to assess interfragmentary strain or a clinically useful
surrogate.] To overcome this, we aim to validate two novel, noninvasive, and complementary methods of
quantifying clinical [fracture site motion]. Method 1) A case-specific computational model will be refined to
estimate [fracture site motion] for 10 human subjects recently treated with locked plate fixation for a distal femur
fracture. Method 2) Biplane fluoroscopy will be used to track [the proximal and distal bone fragments] during
standing and walking for these same 10 patients. The proposed research provides two complementary methods
of assessing [fracture site motion] in future translational research. These methods will be validated via cadaveric
testing. Furthermore, unloaded and loaded CT measurements of [fracture site motion] in the test cohort will [allow
in vivo validation]. Computational modeling provides an indirect, scalable method of estimating [fracture site
motion] while biplane fluoroscopy will provide direct in vivo assessment. Both methods will support future
translational research involving heretofore untestable hypotheses. This includes research into optimal fixation
strategies and rehabilitation protocols, as well as the ability to control for confounding factors in studies of other
aspects of fracture healing. This innovative work aims to overcome limitations in current research to develop two
complementary methods of quantifying patient-specific [fracture site motion, which has been shown to be a
clinically relevant surrogate for interfragmentary strain. A quantitative understanding of fracture site motion will
inform observational studies and clinical trials directly targeting mechanotransduction and allow research
targeting other aspects of fracture healing to account for a potential confounding effect of mechanotransduction.
Further, quantifying fracture site motion is a necessary step toward future quantification of interfragmentary
strain.] This translational study opens multiple avenues of mechanistic and clinical investigation with the potential
for early and long-term clinical impact by decreasing the incidence of fracture [delayed union and] non-union.
[The proposed work will support future Merit Review funding of a prospective observational study of optimizing
fixation strategies and rehabilitation protocols for secondary fracture healing.]

Public health relevance
PROJECT NARRATIVE Complicated bone fractures that require surgery to implant metal plates and screws to hold the parts of the bone together do not always successfully heal, particularly when these fractures are of the distal thigh bone. We know that the amount the parts of the bone are able to move relative to each other after the repair and the direction of these movements can influence the healing process, however we do not understand this process very well nor are we able to measure the small movements between the fragments. In this proposal, we will use two new approaches, computer simulations and X-ray videos taken from two directions, to measure bone movement in patients who have had this injury. [We will also employ CT scans to confirm the accuracy of these methods.] This project will improve our understanding of how the parts of the injured bone move relative to each other in patients who have had this injury, and lead to research that will help doctors to design the bone repair and guide postoperative rehabilitation in a way that will maximize the chances that the bone will successfully heal.